Programming multi-pronged immune response to glioblastoma with IL-13Ra2/TGF-b CAR-T cell therapy.

ABSTRACT
Glioblastoma multiforme (GBM) is the most common type of primary brain tumor, with a five-year survival rate
of only 5.5%. Chimeric antigen receptor (CAR)-T cell therapy has shown safety but limited efficacy in the
treatment of patients with GBM to date. GBM is characterized by dramatic antigen heterogeneity, thus
immunotherapy targeting any single antigen is unlikely to achieve complete and durable response. In addition,
GBM cells and surrounding tumor stroma overproduce transforming growth factor beta (TGF-β), which not only
promotes tumor growth and metastasis, but also actively modulate the immune response by suppressing T-cell
function and recruiting suppressive myeloid cells. Our analysis of patient GBM biopsies further confirmed that
tumor-infiltrating myeloid cells (TIMs) express both TGF-β and TGF-β receptors, indicating the presence of an
immunosuppressive feedback loop in the GBM tumor microenvironment (TME). Here, we aim to develop a multi-
pronged immunotherapy featuring bispecific CAR-T cells that can not only attack GBM directly, but also modify
the TME to overcome immunosuppression and induce multiclonal immune responses against GBM.
Our group has developed a bispecific CAR that can directly target GBM cells through recognition of IL-
13Rα2, a clinically validated GBM-associated surface antigen, while simultaneously converting TGF-β into a
stimulant for the engineered T cells. We have demonstrated that bispecific IL-13Rα2/TGF-β CAR-T cells are
superior to single-input IL-13Rα2 CAR-T cells in both human GBM xenograft and immunocompetent mouse
models. Here, we aim to demonstrate the safety and efficacy of IL-13Rα2/TGF-β CAR-T cells for clinical
translation. In addition to demonstrating clearance of IL-13Rα2+ GBM, we will explore the potential for IL-
13Rα2/TGF-β CAR-T cells to induce endogenous immune response against IL-13Rα2– tumor cells using mouse
models of heterogenous GBM. We will perform in-depth analyses by flow cytometry, multiplexed immuno-
fluorescence, cytometry by time of flight (CyTOF), and single-cell RNA sequencing to understand the impact of
bispecific CAR-T cells on the immune composition and function in the GBM TME. We will also perform T-cell
receptor beta (TCRβ) sequencing on tumor-infiltrating lymphocytes to quantify the potential for epitope spreading.
We will perform rigorous safety evaluations in immunocompetent mouse models, applying worst-case
scenario pressure tests to explore the toxicity profile of IL-13Rα2/TGF-β CAR-T cells. Finally, we will verify
efficacy of IL-13Rα2/TGF-β CAR-T cell therapy in heterogeneous human gliomas ex vivo & in vivo, using both
fresh patient GBM biopsies containing TIMs and GliomaPDOX models—i.e., mice bearing patient-derived GBM
tumors that have never been passaged ex vivo and retain the genetic heterogeneity seen in human patients.
Successful completion of this project will generate a comprehensive set of preclinical data in support of a phase-
1 clinical trial to treat GBM patients with this novel, multi-pronged immunotherapy option.

Public health relevance
PROJECT NARRATIVE We aim to develop effective immunotherapy for glioblastoma multiforme (GBM) by deploying IL-13Rα2/TGF-β bispecific chimeric antigen receptor (CAR)-T cells that can both (a) directly target GBM through IL-13Rα2 surface-antigen recognition and (b) modify the tumor microenvironment by converting TGF-β from an immunosuppressant into a stimulant of engineered CAR-T cells. We will evaluate the ability of IL-13Rα2/TGF-β CAR-T cells to directly eliminate IL-13Rα2+ GBM, as well as to induce endogenous immunity against IL-13Rα2– GBM, in both patient-derived orthotopic xenograft models and immunocompetent mouse models. This work will rigorously evaluate the safety and toxicity profile of IL-13Rα2/TGF-β CAR-T cell therapy, and generate comprehensive preclinical data in support of a phase-1 clinical trial for the treatment of patients with GBM.